Core--Biostatistics

The purposes of the PPG Administrative and Biostatistics Core (ABC) are: 1) to provide statistical expertise to each of the individual projects and investigators of the PPG, 2) to provide consultation on study design, data collection, management, quality control, and statistical data analyses. 3) to provide the opportunity for and to facilitate standardization of experimental methods, variables, and data collection within the PPG, 4) to act as a coordinating center for the PPG in terms of data collection, management, and reporting to internal and outside advisory boards, and 5) to coordinate activities among PPG investigators by providing administrative support for meetings, and by facilitating communication between investigators.